Pilot Project Investigating the PAX3-FOXO1 Protein in the Rare Disease Rhabdomyosarcoma

SUMMARY
The rare childhood muscle cancer alveolar rhabdomyosarcoma (ARMS) is generally not survivable when
metastatic. However, ARMS does usually respond clinically to chemotherapy initially. With respect to the cause
of recurrences, clinicians observe that the translocation-mediated PAX3:FOXO1 chimeric protein present in most
ARMS cases mediates treatment resistance, causing a 45% drop in 10-year survival – a clinical outcome not
associated with the less common PAX7:FOXO1 protein. PAX3, PAX7 and FOXO1 are all individually key
transcription factor proteins in normal muscle, brain and heart development – yet incompletely studied. The
PAX3/7:FOXO1 fusion proteins are even less well characterized. We hypothesize that selective small
molecule inhibitors of these chimeric transcription factor can be designed as probes to uncover these
proteins' molecular, epigenetic, cellular and in vivo functions. Thus, our aim is to: (1) Develop small
molecule inhibitors of PAX3-FOXO1 and PAX7:FOXO1 as tool compounds. Our approach is to establish
PAX homeodomain and paired domain transcriptional reporter assays in a variety of cell model systems with
different epigenetic contexts (skeletal muscle myoblasts, cardiomyocytes, RMS, control fibroblasts and neuronal
cells); counter-screen for an unrelated transcriptional response element target (e.g., NFkB); perform surface
plasmon resonance affinity testing of compound hits with recombinant wildtype and mutant PAX3:FOXO1 or
PAX7:FOXO1 proteins; and perform ARMS cell compartment fractionation to define PROTAC-compatible
nuclear E3 ligases towards generation of a PROTAC tool for PAX3/7-FOXO1. From these studies, we hope to
facilitate the study of PAX3/7:FOXO1 function as transcription factors without necessarily disturbing complexes
(via small molecule inhibitors), and to allow study of epigenetic protein function in real time without secondary
effects (via eventual PROTAC tools).

Public health relevance
PROJECT NARRATIVE Alveolar rhabdomyosarcoma (ARMS) is a rare childhood cancer of the soft tissues. This disease often responds to chemotherapy, but in many patients the available treatments fail --a deadly outcome. We identified how a cancer-causing fused gene called PAX3:FOXO1 leads to treatment failure. The goal of this project is to create chemical tools that allow us to understand the PAX3:FOXO1 and related PAX7:FOXO1 ARMS proteins at the molecular and cellular levels.